Mapping the virus-host interactions that determine interferon resistance of Seoul orthohantavirus

Mammalian hantaviruses (order Bunyavirales, genus Orthohantavirus) are zoonotic RNA viruses that cause
severe vascular inflammatory disease in humans, with case-fatality rates of up to 40%. These negative-sense,
tri-segmented viruses are maintained, persistently and asymptomatically, within wild rodent and insectivore
reservoir populations worldwide. As the first line of antiviral defense, innate immune signaling and type I
interferon (IFN) act to limit viral replication and production of infectious progeny, preventing tissue dissemination
and systemic infection. A dominant hypothesis posits that asymptomatic reservoir persistence is maintained
through innate immune suppression, which allows for sustained viral replication without damaging inflammation.
Evidence to support this hypothesis includes observations by our group and others that hantavirus infection of
natural reservoir target endothelial cells (EC) results in dampened innate immune signaling and IFN-stimulated
gene (ISG) expression. We now show that EC from the natural reservoir host (Rattus norvegicus) for Seoul virus
(Orthohantavirus seoulense, SEOV) support sustained viral replication and infectious virion production in the
presence of exogenous type I IFN and robust ISG expression. In contrast, the related Hantaan virus is highly
susceptible to IFN-mediated restriction in human and rat EC, both of which represent non-reservoir hosts.
Similarly, SEOV replication in human EC was reduced in the context of type I IFN signaling, either through
exogenous treatment or induced by viral recognition receptors. Together, this led to our overall hypothesis that,
through coevolution, SEOV has developed mechanisms to directly target rat antiviral effector proteins induced
by type I IFN and inhibit their functionality. Our data further suggests that mechanisms of inhibition seen in rat
cells are ineffective in the setting of human infection. The unique tractability of the natural rat host and the distinct
divergence in immune modulation provides an opportunity to identify critical SEOV protein – host antiviral protein
interfaces that prevent viral restriction in reservoir, but not human EC. Our team brings decades of experience
in virology, innate immune signaling, and in identifying human host protein interactors for diverse families of RNA
viruses, as well as all of the necessary reagents, assays, and expertise for success. Using novel monoclonal
antibodies directed at each of the SEOV proteins to capture authentic viral protein complexes in the context of
infection, we will undertake an innovative comparative proteomics approach to contrast the SEOV interactome
in reservoir rat and non-reservoir human primary EC (Aim 1). In Aim 2, we will perform validation and functional
analysis of selected IFN-induced antiviral host partners isolated in Aim 1 to test their significance for viral
replication and progeny production in reservoir and non-reservoir host cells. This approach to identify unique
virus-host interactors is the first described for a reservoir host of any hantavirus species and will yield insights
into mechanisms of persistence and human disease.

Public health relevance
Hantavirus disease is a form of zoonotic viral hemorrhagic fever (VHF) that results when humans inhale excreta from hantavirus-infected rodents, with case-fatality rates exceeding 40% for some hantaviruses. In its natural reservoir host, the brown rat, Seoul virus causes asymptomatic, lifelong infection, posing a persistent threat to humans worldwide due to the global rat distribution. This proposal capitalizes on the functional proteomics expertise of the team to identify host-specific interacting partners of Seoul virus proteins that determine resistance to interferon-mediated viral restriction in reservoir host cells, thereby identifying novel effectors to limit viral infection in humans.